Validation of Duoseq as a Genomic Swiss Army Knife for the Diagnosis of Lymphomas

ABSTRACT
DNAseq and RNAseq are powerful and complementary next generation sequencing (NGS) assays for
characterizing cancers. Together, these assays can recapitulate nearly all the diagnostic workup of many tumors.
However, significant barriers prevent its actual application in the routine diagnosis of cancers. First, these assays
are complex and usually separate, with different workflows and timelines for sample preparation. Second, the
bioinformatics analyses needed to interpret the data are complex and difficult to implement. Third, the turnaround
time for NGS assays and analyses typically stretches over a week, making it difficult to incorporate into diagnostic
workups.
To overcome these limitations, we have developed Duoseq, a novel clinical approach for dual DNA and RNA
sequencing from a single workflow. Duoseq also includes bioinformatics software that connects directly to the
NGS sequencer to provide DNA mutations, copy number and translocation status, as well as expression data
for markers recommended by standard clinical guidelines. We have initially developed Duoseq as a solution that
uses DNA and RNA sequencing for the diagnosis of lymphomas.
The average lymphoma biopsy is subjected to a battery of time-consuming diagnostic tests that require
subjective interpretation by pathologists. Duoseq is able to deliver nearly all of these essential molecular
diagnostic readouts including (i) single nucleotide variants, (ii) small insertions and deletions, (iii) translocation
and fusion status, (iv) copy number alterations, (v) immunoglobulin heavy chain variable region mutation status,
(vi) B and T cell clonality, (vi) viral infection status and (viii) diffuse large B cell lymphoma subtypes. Duoseq thus
represents a comprehensive profiling assay that could replace a vast suite of different assays currently used in
the clinic to determine these features, thus saving costs, time and precious biopsy material.
In this Phase II proposal, we will perform a multi-site analytical and clinical validation of Duoseq. These studies
are necessary for an application for FDA approval, which will significantly accelerate Duoseq adoption by clinical
labs. We also propose optimization of an automated, robotics-based version of the Duoseq workflow that will
lower the barrier to entry for clinical labs that are less familiar with NGS assays. Together, these aims will
significantly advance Duoseq toward widespread clinical implementation in lymphoma diagnostics.

Public health relevance
PROJECT NARRATIVE The average lymphoma biopsy is subjected to a battery of time-consuming and expensive diagnostic tests that require subjective interpretation by pathologists. We have developed Duoseq as a novel genomic approach for sequencing DNA and RNA together with included bioinformatics to comprehensively profile lymphomas nearly ten times faster and cheaper than current standard methods. The success of this proposal will accelerate widespread adoption of Duoseq as a comprehensive genomic profiling assay for lymphomas.